Medical Scientist Training Program Training Grant

There is a need to train physician-scientists with an excellent foundation in both biomedical research
and clinical medicine in order to gain a more detailed understanding of disease. The Duke Medical
Scientist Training Program seeks to train MD-PhD candidates in both medicine and science through a
unique curriculum that provides students with comprehensive clinical training prior to their PhD
training. Through this program, Duke MSTP students will be poised to translate scientific discoveries into
therapies for human disease.

Public health relevance
Project Narrative This application builds on the Duke MSTP's long history of training successful physician- scientists by incorporating a number of major changes and improvements, including: 1) Incorporation of improved medical school and graduate school assessment tools to track and evaluate students' progress throughout their training; 2) Development and incorporation of enhanced opportunities for trainees to influence their own career development; 3) Improvement of the admissions process to ensure holistic review and selection of candidates from diverse backgrounds, including enhanced outreach efforts to candidates from historically underrepresented backgrounds; 4) Enhanced trainee oversight at multiple stages of the program, including an emphasis on identification of roadblocks during annual Individual Development Plan meetings between leadership and students; 5) Broadening of the participating faculty to ensure input from a range of outstanding and diverse faculty at all levels; 6) Creation of additional program activities with guidance from the program's trainees and steering committee to ensure adequate program-wide training opportunities that foster program unity, including enhanced vertical integration through Duke's institution-wide Office of Physician- Scientist Development; and 7) Creation of a Diversity, Equity, and Inclusion committee to enhance program initiatives through which all can experience a true sense of belonging regardless of ethnicity, gender, age, national origin, sexual orientation, religious beliefs, or socioeconomic, veteran, or ability status. Collectively, these new program initiatives will continue the Duke MSTP's longstanding tradition of excellence in MD-PhD training and substantially improve outcomes for the approximately 85-90 students in the program each year.